Regulation of Retinal cGMP-Phosphodiesterases

Project summary/Abstract
The long-term goal of this research program is to elucidate the molecular mechanisms
underlying the function and regulation of cGMP-phosphodiesterases (PDE6) in rod and
cone photoreceptor cells. As a central effector enzyme in the phototransduction cascade,
PDE6 is critical to photoreceptor cell physiology and survival. Severe retinal diseases
including retinitis pigmentosa, achromatopsia, and Leber congenital amaurosis result from
pathogenic mutations in genes that encode PDE6 subunits or aryl hydrocarbon receptor-
interacting protein-like 1 (AIPL1), a specialized PDE6 chaperone. Despite our advanced
understanding of the PDE6 regulation in phototransduction, little is known about the folding
and maturation of this enzyme, and the proposed research aims to fill this gap. Our
evidence suggests that AIPL1 forms a complex with ubiquitous chaperone HSP90 that is
absolutely required for maturation of PDE6 into a functional enzyme. We will define the
protein-protein interfaces and the structure of the HSP90/AIPL1 complex in solution to
gain mechanistic insights into how this chaperone complex interacts with PDE6. Based on
our preliminary studies, we hypothesize that nascent PDE6 assumes a closed
nonfunctional state, and the HSP90/AIPL1 complex and the regulatory P-subunit of PDE6
induce and/or catalyze the transition of PDE6 from the closed state to the functional open
state via an intermediate state. We propose a detailed model as to how HSP90, AIPL1
and P facilitate the maturation of PDE6 and will rigorously interrogate this model by
leveraging our heterologous expression system for cone PDE6C in HEK293T cells, and
rod PDEAB in the Pde6g-/-/Pde6ccpfl1 mouse model. In addition, we will use the HSP90
knockout mouse, which highlights the importance of HSP90 in photoreceptor cells
because of its rapid retinal degeneration phenotype, to test our hypothesis that defects in
PDE6 maturation are the key cause of the degenerative phenotype. Elucidation of the
molecular mechanisms of PDE6 maturation will have important implications for retinal
diseases and the design of new therapeutic strategies.

Public health relevance
Project Narrative. cGMP phosphodiesterases (PDE6 family) that are expressed in the rod and cone photoreceptor cells are the key effector enzymes in vision and depend on a specialized chaperone, aryl hydrocarbon receptor-interacting protein-like 1 (AIPL1), and the ubiquitous heat shock protein 90 (HSP90) for their maturation and activity. Mutations in PDE6 and AIPL1 underlie severe retinal diseases in humans, including retinitis pigmentosa, achromatopsia and Leber congenital amaurosis. We aim to elucidate the mechanisms underlying AIPL1/HSP90-assisted maturation of PDE6 to enable development of new therapeutic approaches for treating the visual disorders linked to PDE6 and AIPL1.